NIAID/DIVISION OF AIDS:CLINICAL SITE AND STUDY MONITORING

This initiative provides comprehensive clinical site and study monitoring services for the NIAID/DAIDS extramural HIV/AIDS clinical trial research portfolio.